Mechanisms of type I IFN signaling and HIV risk in the female genital tract

ABSTRACT
Previously, we carried out large-scale analysis of mucosal cytokines and HIV acquisition in high-risk women from
KwaZulu-Natal, South Africa, enrolled as part of the CAPRISA 004 TFV 1% gel study (n = 774). Using a
prospective cohort design, we validated our previous finding that inflammatory cytokines increase the risk of HIV
acquisition. Of the cytokines associated with increased risk, one of the strongest associations was observed for
the key type I IFN, IFN2 (p = 10E-6). Women in upper quartile for IFN2 were at 4-fold greater risk of acquiring
HIV, compared to women in the lowest quartile (HR 3.9, 95% CI 1.7-9.1). On the surface this seems counter-
intuitive, as type I IFN have strong anti-HIV effects both in vitro and when given in vivo as a therapeutic or
prophylactic in non-human primate model. To reconcile these observations, we hypothesize that chronic type
I IFN upregulation in the female reproductive tract (FRT) leads to dysregulation of IFN signaling, resulting
in downregulation of antiviral genes, increase in generalized inflammation and increase in susceptibility
of target cells at the site of infection. This hypothesis would provide an explanation as to why a classical anti-
viral program that should be protective actually leads to higher rates of HIV acquisition. Utilizing samples from
the ongoing CAPRISA 018 tenofovir alafenamide (TAF) sub-dermal implant trial, we will determine whether
prolonged IFN2 upregulation in the FRT leads to decreased IFN responsiveness and IFN-stimulated gene (ISG)
expression in genital immune cells. Next, we will formally test if the chronic increase in IFN2 expression and
ISG downregulation correspond to breakthrough HIV infections in young women enrolled in CAPRISA 018.
Finally, we will use an in vitro PBMC model to determine the mechanism by which prolonged IFN upregulation
leads to ISG downregulation and subsequent increase in HIV risk.

Public health relevance
PROJECT NARRATIVE In this proposal we aim to define the mechanisms of IFN2 induction and its impact on interferon signaling and target cell phenotypes at the site of HIV transmission using longitudinal mucosal sampling from the ongoing clinical trial. In addition to providing crucial information on IFN signaling in HIV infection, the results of this study will provide key information on the role of pre-existing inflammation and the role of timing and duration of exogenous IFN stimulation on generation of potent antiviral immune responses in prevention and treatment of viral infections.